Task C08: Maintenance of Black Fly Immature and Adult Stages

This contract provides for the development and standardization of difficult-to-source reagents that require the use of nontraditional animal models of infectious diseases.